Signaling-regulated establishment of pluripotency in vivo

PROJECT SUMMARY
The first priority of the mammalian embryo is to establish its own placenta, which will eventually be recognized
and accepted by the mother. At the same time, the embryo must reserve fetal cells by endowing some with
pluripotency. Decades of rigorous study have revealed the molecular mechanism that partly explains this first
cell fate decision. Around the 16-cell stage, when the embryo is still a ball of cells, cells on the outer surface
polarize and repress Hippo signaling. As a consequence of Hippo repression, transcription factors YAP and
TAZ (WWTR1) enter the nuclei of the outer cells, where they partner with TEAD4 to promote expression of key
regulators of placental (trophectoderm) fate. Excitingly, this mechanism, which we helped discover in mice, is
conserved in humans, highlighting the utility of the mouse model as a discovery platform. Yet, a major mystery
remained unsolved: how are the pluripotent cells specified? Are they pluripotent by virtue of being non-
trophectoderm? Or is there a more active mechanism? Our lab discovered that the pluripotency factor SOX2
exhibits a unique expression pattern at the 16-cell stage. That is, when other pluripotency factors, such as
OCT4 and NANOG are expressed in both inside and outside cells of the embryo, SOX2 is detected only in
inside cells. This observation suggests that SOX2 helps actively specify the earliest stages of pluripotency.
Through a series of experiments, we subsequently showed that SOX2 expression pattern is dependent on the
YAP/TAZ/TEAD transcriptional complex, indicating that trophectoderm and pluripotency are regulated by
Hippo signaling in parallel, starting at the 16-cell stage. We now seek to discover: 1) Does the SOX2 pattern
provide the positional information to restrict the activity of other pluripotency factors to the inside cells of the
embryo? 2) Do Sox2 paralogues work with SOX2 or other factors to promote the pluripotency of inside cells?
3) How do YAP/TAZ/TEAD mechanistically repress expression of Sox2 while promoting expression of
trophectoderm genes in outer cells? Our team brings together expertise in high throughput genome editing,
time-resolved analysis of single cell gene expression, and ultra-low input genomics, which are all needed to
make the major mechanistic advances envisioned here. These studies will help reveal the generalizable
principles of mammalian embryonic development that are fundamental to ensuring healthy pregnancy and child
development.

Public health relevance
PROJECT NARRATIVE In mammals, including humans, successful pregnancy requires that the newly formed embryo create its own placenta for the mother to accept and later utilize. At the same time, the embryo must also reserve some cells to become the fetus – a process that is less well understood. Using mouse as a model for mammalian development, our team will apply new methods to discover where, when, and how, the fetus is first established to enable healthy pregnancy.